Task C: NIAID Preclinical Services for AMR Diagnostics Development

To provide the capacity and capability for a broad range of services necessary for IVD product development support for promising assays and platforms to detect, identify, and characterize human infectious agents.